Structural and biophysical studies of proteins, nucleic acids, and their complexes

Project Summary/Abstract
There have been no changes to the Project Summary/Abstract for the R35 GM118108 parent
award.

Public health relevance
Project Narra+ve There have been no changes to the Project Narra2ve for the R35 GM118108 parent award.